Minnesota Craniofacial and Oral Health Research Experience

Project Summary/Abstract
The Minnesota Craniofacial and Oral health Research Experience (MnCORE) aims to introduce new
generations of future independent investigators to questions in craniofacial, oral health, and dental research.
Drawing on the research environment at the University of Minnesota, this training program brings together
highly qualified research mentors in state-of-the-art research environments with diverse, talented
undergraduates to engage in a research project. The research strengths of this training program include
immunology/cancer, biomaterials, bone biology and microbiology. The foundation of the program is an
integrated ten-week residential summer research and career development program at the University of
Minnesota. MnCORE has four integrated components: 1) completion of a research project, 2) weekly group
seminars, 3) introduction to oral biology and dental career paths, and 4) development of professional skills. To
help recruit a diverse applicant pool for MnCORE, we are working with North Hennepin Community College/
Bemidji State University, the University of Texas-San Antonio, and the University of Minnesota’s Life Sciences
Summer Undergraduate Research Program (LSSURP). We will also work with LSSURP to engage with other
summer research programs at the University of Minnesota and provide enrichment activities and social support
that complement MnCORE’s goals. To fulfill our training mission with our available resources, we request
support for 8 undergraduate students per year for the 5-year funding period. To ensure we are meeting the
needs of MnCORE trainees, we will use a comprehensive and adaptive evaluation plan for rigorous
programmatic assessment and continuous program improvement.

Public health relevance
Project Narrative Mentoring and supporting underrepresented individuals is essential to developing a diverse pool of researchers for the next generation. The Minnesota Craniofacial and Oral health Research Experience (MnCORE) focuses on exposing undergraduates to dental, craniofacial, and oral biology research through an immersive summer research experience.